Core-002

Engaging stakeholders throughout the full spectrum of the research process leads to better science and,
ultimately, better health outcomes. Yet, the 2014 National Center for Advancing Translational Science
(NCATS) Advisory Council Working Group Report found 1) a paucity of community-driven research; and 2) that
CTSA hubs lack sufficient infrastructure to support the science of community engagement. The Community
Engagement Core (CEC) includes a portfolio of innovative programs and collaborations that demonstrate the
benefits of engaging communities as active partners in research to addresses health priorities. We have
worked to build capacity in the community-engaged research workforce via training, networking, and grants.
Finally, the CEC has consulted with investigators and community stakeholders to optimize research processes
and worked with other CCTST Cores and CTSA hubs to facilitate dissemination and implementation of best
practices. In the Life Sciences, over 90% of published research is by two or more authors (1). The complexity
of the problems studied requires integration of knowledge from many disciplines and the ability to develop and
maintain effective teams. The siloed nature of universities and research institutions is partly responsible for
challenges investigators face when trying to find collaborators from other disciplines. Our Center for
Improvement Science (CIS) has taken a leadership role in developing mechanisms to build broad networks
across disciplines, colleges, institutions, and the community. Our initial cross-disciplinary network has resulted
in over $6 million in funding for interprofessional research and practice improvement projects. The CIS has
also implemented a multi-level team science training program that includes basic to advanced workshops, a
graduate-level course on Collaboration and Team Science, and Grand Rounds. In addition, we provide
consultations for creating teams, improving teams and writing team-based grants. Finally, our expertise in
quality improvement has built bridges between academic and health care systems to form a Learning Health
Care System. We will build on our successful track record in community engagement and team science to:
Aim 1: Further infuse community engagement within the CCTST and across the translational spectrum;
Aim 2: Increase capacity for bi-directional engagement through expansion of educational offerings in
community engagement and team science in translational research;
Aim 3: Facilitate the development of multidisciplinary Learning Communities (LCs) that support the
dissemination and implementation of best practices in community engagement and team science; and
Aim 4: Implement an innovative team science program to enhance the effectiveness of multidisciplinary
research teams.